From the Past to the Future: Chimeric Antigen Receptor T cells for Lymphoid Malignancies

Summary/Abstract (PROJECT 1)
Chimeric antigen receptor (CAR) T cells directed to the CD19 protein (CART19) have revolutionized the
treatment of a variety of B cell malignancies, with complete remission rates as high as 97% in certain types of
advanced leukemia. Many of these responses are sustained, but poor CAR T cell expansion and persistence
following infusion and antigen-negative escape are common mechanisms of treatment failure. It is critical to
investigate factors driving successful CAR T cell function in responding patients. Previous studies have indicated
that in lymphoid malignancies, durable remission is associated with activation of specific T cell pathways and
only some patients experience therapeutic levels of CAR T cell expansion and antitumor activity. During the
previous award period, we successfully developed a comprehensive understanding of the T cell-intrinsic and -
extrinsic mechanisms of resistance as well as tumor cell-intrinsic mechanisms that lead to relapse. Here we
propose extensive next-generation analyses to understand properties of optimal CAR T cell therapy, elucidate
mechanisms of resistance, and develop strategies to overcome resistance and enhance CAR T cell activity to
cure more patients with hematologic diseases. We will take advantage of already established successful
collaborations with core laboratories possessing expertise in cell manufacturing, gene editing, and state-of-the-
art correlative science platforms to explore a number of innovative aims. In Aim 1, we will carry out an extensive
analysis of T cell receptor (TCR) rearrangements, vector copy number, T cell subsets analyzed by flow
cytometry, serum cytokines and biomarkers (~7,000), and transcriptional landscapes of CAR T cells in blood as
well as tumor tissues and formulate multi-omics models linking correlative data and outcome. In Aim 2, we have
designed a high-impact clinical trial to knockout CD5, an unconventional negative immune checkpoint molecule
and inhibitor of antigen-receptor signaling, with the goal of increasing the therapeutic index of 3-day
manufactured CART19 cells for relapsed/refractory B-cell malignancies. Finally, in Aim 3, we will carry out
functional analyses of genes implicated in potentiating CAR T cell proliferation, persistence, and antitumor
function to develop `best-in-class' products for ALL, CLL, and NHL. Using a structured, multi-pronged strategy,
we hope to ameliorate resistance to CAR T cell-based therapies for B-cell malignancies and clinically advance
several next-generation synthetic biology tools. This work is expected to open therapeutic horizons in the field
of adoptive immunotherapy for cancer and offer new research prospects that could be translated to improving
the treatment of other cancers and autoimmune disorders.

Public health relevance
Narrative (PROJECT 1) The goal of this project is to address major challenges and unmet needs of chimeric antigen receptor or “CAR” T cells that currently limit treatment success in patients with blood and lymph node cancers. We propose to identify critical characteristics of effective CAR T cell products to obtain information useful in optimizing therapy and then engineer around resistance mechanisms using cutting-edge gene editing tools with the goal of creating CAR T cells more effective at inducing long-lasting remissions. The proposed research is relevant to public health because it will help increase the potency of CAR T cells used to treat chemotherapy-resistant cancers, which may make this strategy viable and efficacious for many more patients.